Mechanism-Guided Catalyst Development through Reaction Discovery Simulation

Project Summary
Advances in chemical synthesis provide access to complex biologically active structures that
are highly relevant as pharmaceuticals and analysis tools. High performance reactions that
allow selective formation of specific covalent bonds are usually achieved by first uncovering
their fundamental chemical reaction mechanisms, as these mechanistic details pave the way
for further experimentation. Especially in the areas of C-H functionalization, Lewis acid/base
chemistries, and stereoselective transformations, the discovery of mechanism is vital due to
the high difficultly level in achieving these reaction steps. Further development of these reaction
types will enable efficient construction of a wide variety of powerful therapeutics, signaling
probes, and natural products.
The proposed research will leverage first principles simulations to greatly accelerate catalyst
development for novel synthetic reactions. The Zimmerman group's recently developed
reaction pathway discovery tools are especially well-positioned for this task, being able to
reveal unexpected reaction pathways as well as intuitive paths, giving deep insight into the
atomistic details of reactivity. In collaboration with numerous reaction development groups,
these tools have already been used to reveal principles for several classes of catalysts, and
have even allowed new catalyst structures to be designed. Application of these methods to the
proposed transformations (Ni-based C-H functionalization, macrolide glycosylation by chiral
organocatalysts, Lewis-acid catalyzed carbonyl-olefin metathesis, and oxidative enzymatic
transformations) will give the basic scientific insight needed to enable challenging synthetic
steps.
In summary, the proposed development of catalysts for highly selective transformations will
enable synthesis of a variety of scientifically and therapeutically relevant molecules, with
profound implications for the treatment and study of human health.

Public health relevance
Project Narrative Discovery of chemical reaction mechanisms will strongly promote the development of new catalysts for synthesis of biologically active products. The proposed research will not only be highly relevant human health due to applications in pharmaceutical production and patient care, but also lead to better understanding of reaction processes in general. The fundamental scientific outcomes emerging from this proposal will form a basis for explaining and developing a wide variety of useful synthetic chemistries.